Sixth Annual Pediatric Asthma Conference - The Future of Asthma

? DESCRIPTION (provided by the applicant): Seven million children are currently diagnosed with asthma. Asthma disproportionally affects African American and Hispanic children with a higher prevalence, greater severity and increased likelihood of hospitalization and death. Children living in urban areas also show increased asthma prevalence, greater severity, more frequent hospitalization and higher mortality rates. From 2001 through 2009 asthma rates increased in African American children by almost 50%. Asthma is the leading diagnosis for which children are admitted to hospital. Asthma is also one of the leading causes of school absences with asthmatic students missing about 10.5 million school days each year due to asthma exacerbations. Asthma is the most common chronic childhood disease and is a significant cause of childhood disability. This disease encumbers affected children and their families, causing limits to learning, inability to be active and even poor quality of sleep. Asthmatics who avoid activity (either because they are not well medicated or because they are not educated about exercise and asthma) are candidates for poor self-esteem, obesity, hypertension, diabetes, metabolic syndrome, osteoporosis, earlier development of adult onset illness, and even a shortened life-span. Both the high cost of healthcare for hospital admissions and urgent care visits can be reduced and the children's quality of life significantly improved if practitioners and families can be convinced to more consistently follow known ideal methods of care - as embodied in the NHLBI Asthma Guidelines. As part of a multi-faceted asthma quality improvement program started in 2009, Nationwide Children's Hospital began hosting an Annual Pediatric Asthma Conference aimed at providing new information and practical advice regarding asthma care for community and hospital care providers of asthma patients. The 2015 conference seeks to expand through the addition of sessions targeted to specific audiences, marketing to a wider geographic area, and involvement of nationally recognized speakers in the field of asthma care.

Public health relevance
PUBLIC HEALTH RELEVANCE: The successful conference has provided education for health care professionals in the past and now seeks to expand to include school nurses, asthma educators and families. The 2015 conference seeks to expand with the following aims: 1) Provide a full day specialized program for school nurses 2) Expand the conference from regional to national 3) Have national speakers for both days of the conference 4) Have family members participate in the conference as a panel 5) Promote personalized asthma care 6) Provide an informal poster session from local participants. The conference has drawn the largest audience in the Midwest and seeks to grow and include the many different professionals and lay persons who are involved in the care of children with asthma. By providing scholarships for school nurses as was done in the 2014 conference, more frontline health caregivers will be educated and provided with expanded professional networking opportunities. The conference seeks to recruit participants from disadvantaged groups who may not already be receiving asthma education and thus enhance asthma care. Families will be sought to participate in the conference and specifically to join a Family Panel to discuss their perspectives on asthma care. Conference attendance, parking and child care will be provided for these families.